Integration of elasticity, viscosity, and plasticity in cellular mechanosensing

Project Summary/Abstract
The role of mechanics in determining cell phenotype has been intensely studied since pioneering studies showed
that cells in culture respond to differences in the elastic modulus of their environment. Stiffness sensing has
been demonstrated in such varied settings as development, cancer, wound healing, and fibrosis. How cells
sense stiffness remains unclear, partly because of a lack of quantitative data that define exactly what cells sense,
especially in vivo. In particular, the nature of viscoelasticity and non-linear (strain-dependent) elasticity and
mechanical plasticity in normal and diseased tissues is insufficiently characterized, and the contribution of these
mechanical parameters to cell stiffness sensing and behavior is not understood. This proposal extends studies
of elasticity to encompass additional biologically relevant parameters, with a focus on the role of dissipative
processes, and offers the potential to reevaluate current models of mechanobiology and develop new concepts
of the role of time dependent mechanics in biological contexts.
The proposed work builds on a series of our investigations as part of the parent R01 project where 1) we
demonstrated through theory and experiments that faster substrate stress relaxation leads to faster migration of
healthy and diseased human cells, 2) we predicted through an active chemo-mechanical model in both 2D and
3D non-linear elastic microenvironments with increasing matrix stiffness, which correlates strongly with the
change in mitochondrial potential, glucose uptake and ATP levels measured experimentally; and 3) we showed
that physiological and pathological chemomechanical cues can directly regulate the spatial nanoscale
organization. In this renewal our overall goal is to integrate theoretical and experimental studies to address how
dissipative matrix properties regulate cellular metabolism, cytoskeletal activity, and chromatin organization, all
vitally important determinants of cell fate and function. We propose an integrated approach using imaging,
theoretical modeling, and omics data to elucidate the crosstalk between histone deacetylases (HDACs) and
metabolism. We will emphasize understanding how the elastic and dissipative properties of the
microenvironment, along with metabolites that act as histone deacetylase inhibitors (HDACIs), synergistically
regulate HDAC activity and metabolic pathways.

Public health relevance
Project Narrative An integrated approach utilizing computational modeling, in vitro and in vivo experimentation will be used to study the role of non-linear elasticity, viscosity, and plasticity on focal adhesion dynamics and mechanosensing in cells. These theoretical models and experiments will enable us to better understand the impact of changes in tissue viscoelasticity and plasticity that are increasingly documented to contribute to progression of diseases such as cancer and fibrosis.